Post-transcriptional regulatory networks in Chronic Obstructive Pulmonary Disease

Project Summary:
Chronic obstructive pulmonary disease is a leading cause of death worldwide, yet the molecular basis of the
disease is still unclear. While recent large-scale transcriptomic studies have identified many genes whose
RNA levels are altered between COPD cases and controls, there has been comparatively little investigation
in COPD into the post-transcriptional changes in RNAs, which can critically affect protein abundance and
function. Post-transcriptional regulation of RNA is controlled by RNA binding proteins (RBPs), which
regulate their target RNA isoforms in a context-specific manner, and disruptions to the complex network
formed by RBPs and their target RNA isoforms can negatively impact cellular function. Work by our group
and others has shown that multiple RBPs, including IRP2, QKI, and TTP, influence COPD phenotypes. In a
recent transcriptomic analysis of COPD lung tissue, we found over 180 RBPs that are differentially
expressed, suggesting widespread dysregulation of the RBP regulatory network in COPD. The long-term
goal of this project is to generate RBP regulatory networks, identify COPD-specific changes, and
characterize the functional consequences of the network changes. We will build on our previous work
inferring regulatory networks from multi-omic data in disease cohorts and perturbation experiments. In Aim
1, we will develop a method to identify RBP-to-isoform regulatory networks by integrating RBP binding
assays with isoform co-expression data from lung (N = 1,078) COPD transcriptomics studies. Using this
method, we will infer COPD case and control networks and identify COPD-specific network nodes, edges,
and communities (clusters). In Aim 2, we will functionally characterize COPD-associated RBP subnetworks
by knocking down COPD-associated RBPs and determining RBP-RNA interactions to identify RBP
functional isoform targets and refine our network inference method in Aim 1 based on these findings. In Aim
3, we will use long-read sequencing to characterize known and novel transcript isoforms from 60 COPD
lung samples. Using a state-of-the-art proteo-genomics pipeline, we will predict protein-level consequences
of COPD-associated RBP network changes and differential isoform expression. We will confirm these
changes in existing mass spectrometry lung proteomics data from the same study subjects. Our team of
network and RBP biologists, along with experts in COPD and long-read sequencing has the necessary
expertise to identify COPD-specific RBP regulatory changes and characterize their functional effects.

Public health relevance
Chronic Obstructive Pulmonary Disease (COPD) is a leading cause of death worldwide, yet its molecular basis is not well understood. In this project we will study the COPD-specific effects of RNA binding proteins (RBPs), a class of molecules critical for regulating RNA as part of its translation into protein. Using a combination of tools from network science, molecular biology, and genomic sequencing, we will investigate how the complex networks formed by RBPs and their targets are dysregulated in individuals suffering from COPD.